Integrative prediction of seasonal influenza evolution by genotype, phenotype, and geography

Project Summary/Abstract The rapid evolution of seasonal inﬂuenza requires the development of a new inﬂuenza vaccine by the World Health Organization (WHO) every one to two years. This evolution occurs through a process of antigenic drift where amino acid mutations in the hemagglutinin (HA) surface protein allow currently circulating viruses to evade adaptive immunity against previous vaccine viruses. Therefore, globally successful seasonal inﬂuenza viruses are often antigenically distinct from previous lineages. High-quality experimental assays for antigenic drift are laborious and low-throughput, leading researchers to develop computational models that can predict the success of inﬂuenza viruses from HA sequence data alone. Since the publication of these original sequence- only models in 2014, there have been signiﬁcant advances in inﬂuenza virology and computational methods that could beneﬁt inﬂuenza predictive models. Speciﬁcally, there are now computational methods to measure antigenic drift by accurately inferring missing measurements in HI assays, high-throughput mutagenesis assays to measure functional constraints on mutations in HA, research supporting the importance of proteins other than HA for inﬂuenza's ﬁtness, and detailed analysis of inﬂuenza's variable geographic circulation. I propose to create a new predictive model of inﬂuenza evolution that integrates these modern, biologically-informed ﬁtness metrics into a single framework. These new metrics will build on dense, high-quality HI assays from collaborators at the Centers for Disease Control and Prevention (CDC), deep mutational scanning assays of seasonal inﬂuenza from collaborators in Dr. Jesse Bloom's lab, a curated database of whole genome sequences for inﬂuenza, and empirical estimates of inﬂuenza's global migration rates. This new predictive model will improve the accuracy of predictions about which viruses are most likely to succeed in future inﬂuenza seasons. These improved predictions will inform recommendations by Dr. Bedford to the WHO at annual vaccine design meetings and, thereby, effect improvements in vaccine efﬁcacy and reduce inﬂuenza-related morbidity and mortality in human populations.

Public health relevance
Project Narrative Accurate prediction of seasonal inﬂuenza evolution depends on a comprehensive integration of biologically rel- evant viral characteristics. This study will integrate inﬂuenza genome sequences, experimental assays, and patterns of geographic distribution into a novel uniﬁed predictive model. The predictions from this model will directly inform vaccine strain recommendations made to the CDC and WHO for all four seasonal inﬂuenza sub- types.